Chronic sleep disruption is a stressor for healthspan and lifespan

Project Summary.
All animals, including humans, require sleep. Sleep deprivation or sleep disruption is a potent stressor.
In animals, complete sleep deprivation for just a few days can be lethal. In humans, chronic sleep disruption
(CSD) is associated with an increased risk of age-related diseases. CSD is more prevalent among working adults
with irregular work schedules, and individuals of lower socioeconomic status (SES) are more likely to work
outside regular daytime hours. Therefore, the health consequences of CSD can contribute to health disparities.
However, chronic sleep disruption in humans also inadvertently leads to several lifestyle changes,
including increased consumption of energy-dense diets, which are themselves associated with a higher risk of
age-related diseases. Furthermore, some evidence suggests that CSD may elicit counter-regulatory
mechanisms that attenuate its adverse effects. Consequently, it remains unknown whether CSD interacts with
the biological mechanisms of aging to increase the risk of age-related diseases. Understanding the link between
CSD and these biological mechanisms will reveal whether it contributes to reduced health span and lifespan
associated with health disparities.
Rodent models of acute sleep disruption lasting up to a few days replicate several key findings from
comparable sleep disruption in humans under controlled conditions. However, after a few days of recovery sleep,
these phenotypes revert to normal. Therefore, studies of longer-term chronic sleep disruption (CSD), different
doses of CSD, sex-specific effects of CSD, and whether it affects disease-free lifespan (health span) or total
lifespan are needed. Advances in the mechanisms of aging, leading to their synthesis into the hallmarks of aging,
offer a mechanistic framework to evaluate whether long-term CSD affects one or more of these hallmarks.
To circumvent the technical challenges of longer-term CSD in mice, this proposal will use a validated
method of automated, programmable, gentle tactile perturbation of resting animals to deliver different levels of
sleep disruption in adult male and female mice. In Specific Aim 1 (R61 phase), adult mice will be subjected to
increasing doses of CSD for several weeks. A multidisciplinary team with complementary and project-relevant
expertise will systematically assess the impact of CSD on specific hallmarks of aging in selected tissues and cell
types to identify how different doses of CSD impact these hallmarks. Next, in Aim 2 (R33 phase), adult mice will
be subjected to a selected dose of CSD for one year. Various validated markers of health and disease will be
systematically evaluated at periodic intervals. Lifespan and cause of death will be determined in CSD and control
mice. Completion of these experiments will offer a comprehensive framework of how CSD intersects with
biological mechanisms of aging and can potentially offer testable hypotheses on which pro-longevity
interventions can attenuate the adverse effects of CSD and thereby reduce health disparities.

Public health relevance
Project Narrative Chronic sleep disruption, widespread in the general population, is known to increase the risk for several diseases, but whether chronic sleep disruption accelerates aging process is unknown. This proposal will test the impact of chronic sleep disruption on some of the hallmarks of aging in both sexes of mice and will also test if a period of chronic sleep disruption reduces disease-free as well as total lifespan.